A MATURE BRAIN ARCHITECTURE KNOWLEDGE MANAGEMENT SYSTEM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The long-term goal of the proposed research is to create a fully functional online workbench for obtaining information about the biological circuits that make up the brain, and for modeling the functional organization of this circuitry in health and in a broad range of neurological diseases, including Alzheimer's, chronic pain, epilepsy, multiple sclerosis, Parkinson's, stroke, and narcolepsy. One strength of this approach in early stages of development is that it complements experimental systems neuroscience research in the lab on the fundamental structural and chemical organization of limbic system circuits that control the basic drives and emotions, along with learning and memory. The foundation of the neuroinformatics research proposed here is a functioning, relatively heavily used website begun in 2001 and called the Brain Architecture Knowledge Management System (Google: BAMS). It is currently the only online system that integrates neuroscience information at four levels of organization: gray matter Regions, neuronal Cell Types making up regions, white matter axonal Connections between regions and cell types, and expressed Molecules. PUBLIC HEALTH RELEVANCE: All of the major neurological diseases are studied in animal models including rat. The goal of the proposed research is to create a widely used online website for accessing information about the structure and chemistry of brain circuits and systems involved in health and disease, and for modeling the basic wiring diagram of the brain and how it is affected in specific neurological diseases, treated in specific ways.